Dissecting Key Interactions of the HTT Transcription Coupled Repair Complex

Project Summary/ Abstract
Huntington’s Disease (HD) is a devastating neurological disease with no available disease modifying therapies.
Accordingly, there is a dire need to identify new therapeutic targets that can slow down disease progression
and improve symptoms. HD is an inherited autosomal disease caused by expansion of the CAG repeat
sequence in the Huntingtin gene, resulting in structural atrophy of the striatum and cortex. Approaches to
reduce the levels of mutant Huntingtin protein in the brains of patients have so far been unsuccessful in clinical
trials, so it is essential to identify new therapeutic targets. Studies have found genetic variants of multiple DNA
damage repair proteins that affect the age of onset of HD. This, combined with the accumulation of DNA
damage seen in HD brains and models, implicates defective DNA damage repair as a critical driver of the
pathology of HD.
Wild-type Huntingtin protein is part of a transcription coupled DNA damage repair complex in neurons, termed
the transcription coupled non-homologous end joining (TC-NHEJ) complex. This complex is recruited to genes
being actively transcribed, so that DNA double strand breaks can be quickly repaired, preserving genomic
integrity and neuronal survival. Huntingtin interacts with numerous DNA damage repair proteins in this complex
including PNKP, and DNA-PK. Interestingly, our preliminary data also show TAR DNA-binding protein 43 (TDP-
43) is associated with Huntingtin TC-NHEJ complex, and this interaction increases after DNA damage. TDP-43
is expelled from the nucleus and phosphorylated TDP-43 accumulates in the cytosol in several neurological
diseases including HD. Another hallmark of HD is the increased level of protein SUMOylation. DNA damage
repair proteins are also often regulated by SUMO, so it is important to learn how post translational
modifications affect TC-NHEJ activity in unaffected and HD cells.
The working hypothesis of this proposal is that incorporation of mutant Huntington into the TC-NHEJ DNA
repair complex disrupts critical protein-protein interactions and promotes excess SUMOylation, resulting in
decreased DNA damage repair and accumulation of DNA damage. Identifying critical protein interactions and
post-translational modifications to boost DNA damage repair in HD will provide a new spectrum of potential
therapeutic targets. To accomplish this, I will define the relationship between the SUMO E3 ligase PIAS1 and
PNKP (Aim 1). I will identify the interface between these two proteins and design mutant iPSC lines to
determine if disrupting binding between these two proteins improves DNA damage repair in HD lines. I will
investigate whether TDP-43 is essential for activity of the TC-NHEJ complex (Aim 2), and how its
phosphorylation and expulsion from the nucleus affects DNA damage repair. I will identify the E3 SUMO ligase
for TDP-43 (Aim 3) to enable studies which modulate TDP-43 SUMOylation.

Public health relevance
Project Narrative/ Relevance Huntington’s Disease (HD) is a devasting terminal disease with no disease modifying treatments. DNA damage accumulates in HD patients, contributing to neuronal death. The goal of this project is to identify key protein interactions and post translational modifications of DNA damage repair proteins which can be modulated to improve HD phenotypes.